Development and characterization of engineered therapeutic antibodies against SARS-CoV-2

PROJECT SUMMARY/ABSTRACT
The cell-to-cell spread of pathogenic tau between neurons is a devastating hallmark of Alzheimer’s disease (AD)
and other dementias. Recent evidence indicates that the neuronal receptor low-density lipoprotein receptor-
related protein 1 (LRP1) is the critical receptor required for endocytosis of pathogenic tau, suggesting the
blocking of LRP1-tau interactions as a therapeutic route. However, to achieve this requires comprehensive
atomic-level characterization of LRP1-tau engagement, as well as the identification of potent molecular inhibitors
and characterization of their mechanism of action. Work in the supplement, in response to NOT-AG-21-018
entitled “Alzheimer’s-Focused Administrative Supplements for NIH Grants that are Not Focused on Alzheimer’s
Disease” directly addresses key gaps in treatment of Alzheimer’s Disease in the context of blocking pathogenic-
tau. We demonstrate that LRP1 directly engages tau, which we will block with our recently discovered Rift Valley
Fever Virus glycoprotein N (RVFV Gn) that also directly binds LRP1. Using protein engineering, we will build
multivalent tau inhibitors, test their efficacy in tau binding and spreading, and evaluate the impact in a mouse
model. We will test the significance of Lrp1 in mouse models of AD. Altogether, this work will provide the
framework needed to develop potential viral glycoprotein-based therapies to prevent the spread of pathogenic
tau, addressing an urgent unmet need.

Public health relevance
PROJECT NARRATIVE (RELEVANCE): Propagation of pathogenic tau throughout the brain is implicated in Alzheimer’s disease (AD) initiation and progression and is a critical step that can be therapeutically targeted. We will engineer viral tau uptake inhibitors using a recently identified viral protein and validate its efficacy. Our studies are poised to address a critical gap in AD research.